Development of a pre-clinical syngeneic pig glioma model for research and translational studies

Glioblastoma (GBM) is uniformly fatal with an incidence rate of 2.99-3.23 per 100,000 people. Despite recent
therapeutic advances, our understanding of tumor biology in GBM remains incurable with median survivals of
less than two years. Critical unanswered questions contributing to this dismal prognosis that elude clarification
through traditional analysis of human clinical material or small animal models include i) how does surgical trauma
impact GBM development and adjacent brain tumor microenvironments, ii) what are the unique cellular and
molecular properties of residual infiltrating tumor cells during disease progression, and iii) how do surgically
induced selection pressures generate de novo molecular and cellular heterogeneity not present in unresected
surgical samples. Development of a cure or at least a treatment that would provide significant quality of life
improvements in GBM patients is ultimately limited by the lack of animal models that reproduce the hallmark
features of GBM tumor. Typically, rodent models are used to study GBM; however, rodents differ vastly from
humans (e.g., brain size and complexity), making surgical interventions difficult to simulate. By contrast, the mini-
pig brain is remarkably like the human brain and its larger size permits relevant surgical and imaging studies.
Therefore, we propose to develop a first-in-kind syngeneic (intact immune system) glioma model in mini-pigs to
recapitulate hallmark features of human glioma. Development of this model will support studies heretofore
impossible in rodent models or human patients. Thus far, we have established oncogene activated transformed
pig glioma cell lines from pig brains and confirmed their tumorigenic capabilities in mouse models and onco-
minipigs. In the proposed research, we will determine the optimum engraftment conditions of these oncogene
activated transformed pig cells by implanting them into host pig brain under chronic vs transient
immunosuppressive microenvironment. We will also study the impact of provincial treatment of anti-inflammatory
and immune suppressive drugs. To eliminate any potential impact of immune activation between different donors
and hosts, we will repeat the same approach to induce in vivo viral oncogenesis. The relevance of the proposed
syngeneic pig model will be established through analysis of accepted hallmark MR imaging, stereotactic guided
intracranial surgery, and pathology features of the human disease, followed by immune phenotyping.
Development of a large animal glioma model is expected to facilitate new insight into human glioma biology. As
a first step, we propose to test the hypothesis that mini-pig syngeneic glioma models will recapitulate key features
of the human disease. Further, these models are expected to provide a robust new platform for future studies
not possible in rodent models or practically achievable through analysis of patient-derived material. This includes,
but is not limited to, the evaluation of new therapies, imaging studies, and surgical techniques. Finally,
development of this large animal model will enable not only us, but the larger scientific community, to answer
clinically relevant questions applicable to GBM and other brain metastatic cancers.

Public health relevance
Narrative Current mouse models of the highly lethal Glioblastoma (GBM) are not clinically relevant in humans due to huge dissimilarities of size, structure, and physiology. Here, we propose to develop a large animal syngeneic pig glioma model using a local anti-inflammatory treatment and the innate immunosuppressive microenvironment with optimum engraftment conditions at implantation site of oncogene activated transformed pig neural progenitor cells (Tr-pNPCs) or Cre-responsive virus. This first-in-kind, clinically relevant syngeneic pig GBM model will better recapitulate human brain physiology, improve clinical imaging, predict treatment responses, and ultimately provide better outcomes in GBM patients as compared to current GBM mouse models.